Mechanism of ARIA following Anti-Amyloid Immunotherapy

PROJECT SUMMARY
Monoclonal antibody (Ab)-based immunotherapy to remove amyloid-beta (Aβ) holds great promise for treating
AD patients. However, potential severe consequences, including excessive inflammation, increased risk of
bleeding in the brain, and potential death, have raised concerns regarding the safety of anti-amyloid
immunotherapy.
To develop efficient strategies to safely administer anti-amyloid immunotherapy, it is critical to identify the
mechanisms leading to Amyloid-Related Imaging Abnormalities (ARIA), such as cerebral edema and
microhemorrhages that are induced by immunotherapy. To address this, we cloned the human anti-Aβ antibody
Aducanumab (Adu) and Lecanemab (Lec) and further murinized them on mouse IgG2a. While these chAbs were
effective in reducing Aβ in the brain, the chronic administration of these chimeric Abs (chAbs) recapitulated MRI-
detectable ARIA events in AD model mice.
Our preliminary studies found genes associated with vascular inflammation that were dysregulated in brain
endothelial cells, and that the elimination of chAbs from the brain was significantly reduced in aged AD model
mice. Thus, it is reasonable to surmise that the prolonged retention of immunogenic chAbs in the brain may cause
excessive vascular inflammation. We hypothesize that the low clearance of anti-amyloid Abs in the AD brain is
directly linked to the development of ARIA events through increased vascular inflammation. Using clinically
relevant but conformationally distinct ChAbs raised against dense plaques (ChAdu) and protofibrils (ChLec) of Aβ,
Aim 1 focuses on determining the elimination pathway and the mechanism of clearance for chAbs in AD mouse
models. In Aim 2, using a biophase PK/PD model, we will examine how ARIA events develop in AD model mice
receiving chronic administration of two conformational ChAbs. We will assess PK/PD relationships between chAbs
and ARIA profiles, cognitive function, and immunotherapy associated exacerbation of CAA in AD model mice
with and without ARIA. In Aim 3, we will examine the mechanisms of vascular inflammation that exacerbate
vascular deposition of Aβ aggregates in immunotherapy treated animals. Understanding vascular inflammation
profiles between ARIA-positive and ARIA-negative mice will identify the inflammatory pathways involved in the
development of ARIA in AD model mice receiving immunotherapy, which may allow for adjunctive anti-
inflammatory treatments to reduce risk.
The completion of this project will provide insights into the mechanisms underlying ARIA events caused by
clinically relevant anti-Aβ antibodies directed against two distinct conformations of Aβ. Ultimately, this project will
contribute to the development of management strategies to ensure the safe application of immunotherapy in AD
patients.

Public health relevance
PROJECT NARRATIVE While anti-amyloid immunotherapy for Alzheimer's disease (AD) has shown promise for treating patients, potentially severe consequences have raised concerns regarding the safety of the treatment. This project aims to determine the mechanism of amyloid-related imaging abnormalities to develop efficient strategies to manage the safe application of immunotherapy.